Cancer Research Training and Education Coordination

The Rogel Cancer Center (Rogel) is dedicated to training and developing the next generation of cancer
researchers and providers. Rogel established the Training, Education and Career Development (TrEC)
Office to lead coordination and development of programming for all levels of trainees and across the continuum
from basic to population research. Rogel boasts an exemplary track record of established NCI- funded
research training programs for over 30 years. Graduates from Rogel-affiliated training programs – from basic
research to population sciences – serve as leaders in major academic centers across the country. Through its
TrEC initiatives, Rogel has had a sustained and prominent impact on cancer research and the training of the
oncology workforce nationally and internationally. Rogel trainees have achieved success across all levels and
relevant metrics, further solidifying the major and sustained impact that Rogel has had on developing future
cancer researchers and leaders. Rogel TrEC coordinates and provides cancer-focused training and career
development opportunities for all levels of trainees, and as result, serves a key bridging role in engaging
trainees in cancer-related career development and linking trainees to each other and to members outside their
home units. Rogel fosters a training environment that robustly supports transdisciplinary, translational and
team science in cancer research as well as Rogel cross-cutting research themes and catchment area priorities,
while ensuring the individual career development of future cancer research leaders. Faculty members and
trainees participate in educational outreach initiatives in partnership with Rogel Community Outreach and
Engagement (COE) initiatives to further inform their learning about the CA and high priority cancers.